Development of novel metastatic mouse models that recapitulate the major immune contexts of human colon cancer

The purpose of this proposal is to develop novel mouse models of colorectal cancer (CRC) with appropriate
immune responses. These models have been designed to address limitations present in current models of
CRC in order to enhance their suitability for translational research in immunotherapy. Immune checkpoint
inhibitors have revolutionized treatment of solid tumors, and brought to light the critical importance of tumor
immune context in treatment outcome. CRC with DNA mismatch repair (MMR) deficiency is characterized by a
high burden of somatic mutations, increased T cell infiltration, and a favorable response to checkpoint
blockade. Unfortunately, the majority of CRC has a lower mutational burden and is refractory to these
treatments. Preclinical mouse models are powerful platforms for investigating the factors underlying response
to immunotherapy. However, no single model faithfully recapitulates primary tumor development in the colon
microenvironment, metastatic dissemination to the liver and lung, and the major immune contexts underlying
variability in immunotherapy response in human CRC. To address these significant translational deficiencies,
we will use an innovative technique employing colonoscopy-guided sub-mucosal injection of lentivirus or tumor
organoids to induce focal autochthonous and orthotopic tumors in the colon that readily metastasize. In Aim 1,
we will engineer a model that modulates tumor immunogenicity through inducible expression of a model
antigen. We will dissect the features of the induced anti-tumor T cell response and investigate the utility of this
model for testing adoptive T cell therapy by transferring antigen-specific T cells. To potentiate adoptive T cell
therapy and mirror ongoing clinical trials in humans, we will assess the efficacy of CRISPR-Cas9-mediated
deletion of immune checkpoints in T cells prior to transfer. In Aim 2, we will model immunotherapy-responsive
CRC by targeting the essential DNA MMR genes Msh2 and Mlh1 and use next-generation sequencing to
characterize the mutational landscapes of resulting MMR-deficient versus proficient tumors. In Aim 3, we will
perform preclinical trials of immune checkpoint blockade in these models to explore their ability to recapitulate
the responses of human CRC patient populations. We will also test a novel combination of immunogenic
chemotherapy and checkpoint blockade, based on the hypothesis that immunogenic cell death may sensitize
tumors with low mutational burden or minimal pre-existing T cell involvement to immune attack. This strategy is
aimed at improving treatment for the majority of CRC patients, whose tumors are non-immunogenic and non-
responsive to immunotherapy. The overarching goal of this research plan is to develop and benchmark a set of
highly comparable CRC models that will be used to address why only a fraction of patients respond to
immunotherapy. The proposed strategy is innovative in that it uses cutting-edge methods in mouse genetic
engineering and cancer modeling to capture critical features of human CRC. This research will also include
deep characterization of the immune microenvironment in these models and a comparison to humans.

Public health relevance
Recent clinical breakthroughs have led to FDA approval of multiple immune checkpoint blockade therapies in diverse cancer types, with unprecedented durable clinical responses. However, the majority of colorectal cancer patients remain largely refractory to these promising therapies. This project aims to develop novel mouse models that address critical translational gaps in current models for the development and preclinical testing of more effective immunotherapies for colorectal cancer.